IGF::OT::IGF::C101597 - A-E SERVICES FOR DOCUMENTING SEQUENCE OF OPERATIONS AND SYSTEMS DIAGRAMS AT BLDG 11-BETHESDA, MD CAMPUS

Funding provided for technical review of the design documents of the construction projects in Puerto Rico (grant# C06 OD026690), PI: Martinez, Melween and grant# C06 OD026689, PI Sariol, Carlos). These projects are a part of the effort to restore HIV/AIDS-related research infrastructure destroyed by the hurricane Maria.